Leveraging ultra-fast Cherenkov emission in scintillator-based TOF-PET by exploiting photon wavelength classification

Project Summary (Abstract)
We propose to separate scintillation and Cherenkov photons produced in scintillator crystals to improve the time
and energy resolution of time-of-flight positron emission tomography (TOF-PET) detectors far beyond those
achieved in state-of-the-art systems. With its pico-molar sensitivity and a few millimeters of spatial resolution,
TOF-PET is the leading nuclear imaging modality for a number of diseases, from cancer to neurological and
cardiovascular disorders. A significant improvement of the coincidence time resolution (CTR) and energy
resolution would boost the signal-to-noise ratio and hence enhance image quality, resulting in more accurate
diagnoses, lower patient doses and exposure times, and granting access to a new broad range of applications
for TOF-PET. The ultra-fast picosecond emission of Cherenkov light has demonstrated to achieve the best CTR
ever reached of 30ps FWHM using PbF2, a pure Cherenkov emitter. However, this provides a very poor energy
resolution due to the low light yield of Cherenkov emission. The combination of Cherenkov and scintillation
emission has been proposed as a way to obtain both good time and energy resolution, which has been
demonstrated in bismuth germanium oxide (BGO), a high stopping power scintillator for PET, to obtain a CTR of
120ps FWHM with an energy resolution of 14%. The main reason why it is very challenging for BGO to reach
CTRs of 30ps FHWM is due to the presence of the slower scintillation light and the inability of current detectors
to disentangle between Cherenkov and scintillation. Additionally, the difference between the Cherenkov and
scintillation light emission spectra, makes it very hard to obtain a BGO detector that provides both good time and
energy resolution. We propose to separate Cherenkov and scintillation photons in order to provide a detector
that can be optimized independently for each of the signals, maximizing time resolution with Cherenkov and
energy resolution with scintillation without hindering each other. This separation can be achieved by exploiting
the different emission spectra of each mechanism using dichroic filters, which are able to classify photons by
wavelength with a negligible photon loss. This project aims to 1) obtain a CTR of 50ps FWHM and reduce the
scintillation background by a factor of 5 through wavelength classification in BGO, 2) increase photon
detection efficiency in BGO by at least a factor of 2 without compromising time resolution, and 3) reach
a CTR of 30ps FWHM with a 7% energy resolution by leveraging the hybrid Cherenkov-scintillation
concept with thallium chloride (TlCl). This project will pioneer the exploration of wavelength information as a
way to dramatically improve TOF-PET performance. We will combine this technique with other cutting-edge
technologies such as fast or high quantum efficiency photosensors, in order to demonstrate a novel a cost-
effective approach to a next generation TOF-PET. Our goal is to enable a new technology that can bring CTR
closer to the 10ps FWHM milestone with a good energy resolution in order to be further exploited in future
projects for the construction of a full TOF-PET system.

Public health relevance
Project Narrative (Relevance) Time-of-flight positron emission tomography is the standard of care in nuclear imaging for a broad range of diseases, from numerous types of cancer to neurological and cardiovascular disorders. To achieve a good spatial resolution and image quality, an excellent time and energy resolution are required. In this project, we aim to demonstrate a novel way to improve both simultaneously by exploiting the information carried by the wavelength of the optical photons generated in scintillator materials.